A Pragmatic Trial of Parent-focused Prevention in Pediatric Primary Care

Fifty percent of all adolescents will use some form of illicit drugs before the end of high school, 20-25% will
meet criterial for depression, and many others will engage in health compromising behaviors like delinquency
and violence—with consequences for their long-term health. Evidence-based interventions shown to prevent
these behavioral health concerns could improve adolescent health trajectories if implemented widely in pediatric
primary care. The American Academy of Pediatrics’ Bright Futures recommends that pediatricians offer
developmentally tailored anticipatory guidance to all parents to support their children’s healthy development, but
programs providing guidance are not offered universally. This UG3-UH3 application tests the feasibility and
effectiveness of implementing Guiding Good Choices, a universal, evidence-based anticipatory guidance
curriculum for parents of early adolescents, in three large, integrated healthcare systems serving
socioeconomically diverse families. This intervention reduced adolescent alcohol, tobacco and marijuana use,
depression, and general delinquency in two previous rigorous randomized controlled trials. It also strengthened
parenting practices and parent-adolescent relationship quality, both broadly protective against behavioral health
concerns. Guiding Good Choices has the capacity to achieve population-level impact on adolescent health if
made widely available through pediatric primary care. Parents trust pediatricians’ advice regarding their
children’s well-being, and current research with socioeconomically diverse groups suggests that they are eager
to participate in family-focused programs offered in primary care clinics. Building on this body of research, the
investigative team, in close cooperation with the NIH Healthcare Systems Research Collaboratory and
healthcare systems partners, will conduct a cluster-randomized trial of Guiding Good Choices in 72 pediatric
primary care practices. Half will be randomly assigned to offer the program universally to parents of adolescents
ages 11 to 12, and half will serve as usual care controls. The study will use a workflow that is easy to adopt,
implement, and maintain by primary care clinics to enroll families in the intervention at the adolescent well visit.
We anticipate recruiting over 4,500 families into the trial. The team will use the RE-AIM framework to test
implementation outcomes and effectiveness, including hypothesized reductions in several behavioral health
problems (e.g., substance use initiation, mental health symptoms and diagnoses), and emergency department
and inpatient service utilization. We will use data from the EHR and a supplemental behavioral health survey to
monitor outcomes up to 3 years post intervention. We will also assess the feasibility and sustainability of
implementing the intervention in each HCS, including health economic evaluation to understand costs in relation
to value gained. Throughout the trial the investigative team will engage in ongoing dialog with HCS leaders,
pediatricians, and clinic staff to ensure the intervention and implementation process fit the needs of each HCS.
We anticipate that evidence of feasibility and effectiveness in three different HCS will foster broad dissemination
to achieve public health impact.

Public health relevance
Pediatric primary care is an opportune place to deliver evidence-based parent education programs to prevent substance use, depression, anxiety, and antisocial behavior, problems that rapidly increase during the teenage years, often with lifelong negative health consequences. This large pragmatic trial tests the feasibility and effectiveness of providing universal, evidence- based anticipatory guidance and education to parents of early adolescents in the course of routine pediatric primary care. Our partnership with pediatricians and healthcare leaders in three large integrated healthcare systems, as well as the NIH Healthcare Systems Research Collaboratory, will help ensure our approach fits pediatric care workflows so that, if effective, it will be ready for broad dissemination to achieve public health impact.